Improved Globin Expression Vectors for Gene Therapy of Human Hemoglobinopathies

PROJECT SUMMARY A lentiviral vector (CCLc- βAS3-FB {βAS3LV}) is being investigated for the treatment of severe sickle cell disease, however, it suffers from low titer, sub-optimal gene transfer to CD34+ hematopoietic stem cells (HSCs), and expression likely insufficient to definitively cure β-thalassemia (although sufficient to prevent sickling in pre-clinical studies). We hypothesize that there are known and unknown human β-globin genomic sequences within βAS3LV that are inhibiting vector performance. Studies outlined in this proposal will investigate how removal and/or addition of known or unknown elements within βAS3LV's human β-globin genomic sequences affect titer, gene delivery to HSCs, and expression of the anti-sickling βAS3-globin gene. The outcome of these studies will provide insight into how specific regulatory elements influence the performance of βAS3LV across multiple categories. Moreover, this research will yield a second generation of improved lentiviral vectors for efficiently transferring and effectively expressing the anti-sickling βAS3-globin gene for gene therapy of sickle cell disease.

Public health relevance
PROJECT NARRATIVE This proposal will provide insight into how combinations of specific regulatory elements influence the performance of β-globin lentiviral vectors across multiple categories. These studies will produce a β-globin expression vector with expression levels similar to that of the endogenous β-globin allele and may also reveal some functional insight into how the human β-globin Locus Control Region, a regulatory element that influences the expression of globin genes, functions at a level not previously studied.